A Pilot Clinical Trial for Speech Neuroprosthesis

PROJECT SUMMARY
Neurological injury that results in the loss of communication is devastating. This proposed pilot trial is designed
to evaluate the feasibility of speech prosthetic technology in a small cohort of paralyzed patients. We will leverage
a decade-long scientific investigation of the functional properties of human speech motor cortex, and recent
demonstration of speech decoding in normally speaking patients implanted with electrodes (for epilepsy surgery
planning). We propose an early feasibility study of a long-term direct neural interface for restoration of
communication. We propose three critical innovations to achieve this goal: 1) a chronically implanted high-
density 128 channel electrocorticography (ECoG) array which samples from the entire lateral motor cortex
(including speech motor cortex), 2) application of state-of-the-art neural network decoding approaches, and 3)
direct comparison of text and speech synthesis decoder approaches. Electrocorticography is a method of
recording neural activity (local field potentials) from the brain surface using non-penetrating electrodes. We
hypothesize that ECoG may have distinct advantages for clinical application over current alternatives (e.g.
microelectrode or scalp EEG) given that we can achieve both high-density sampling and cover the entire speech
motor cortex. We have previously demonstrated that this scale and coverage is necessary and sufficient to
decode speech in intact individuals. ECoG has an increasing well documented safety and reliability profile for
long-term implantation in human medical applications such epilepsy and brain computer interfaces. We have
already de-risked regulatory hurdles with FDA IDE and local IRB approval for investigational use. The primary
goals of the study are to enable communication via text and synthesized speech decoded from neural signals.
The secondary goal is to demonstrate the robustness and stability of ECoG-based recordings in the chronic
implantation setting. These aims will determine the feasibility of speech neuroprosthetic technology in target
population of patients who are paralyzed.

Public health relevance
PROJECT NARRATIVE We propose a pilot clinical trial of a speech neuroprosthetic device for patients with severe paralysis, resulting from stroke, amyotrophic lateral sclerosis (ALS) and progressive muscle disorders. This is a critical step towards a clinically viable technology to restore communication and quality-of-life for affected individuals.